DICHLOROACETATE IN TREATMENT OF CONGENITAL LACTIC ACIDEMIA

Evaluation of treatment of children with congenital lactic acidosis due to inborn errors of mitochondrial metabolism with sodium dichloroacetate (DCA), an investigational drug known to lower blood lactic acid levels in such individuals.